Chemically modified peptide nucleic acids

Our research on Peptide Nucleic Acids (abbreviated as PNAs) focuses on introducing chemical modifications that will make this class of molecules broadly useful to detect sequences of DNA. Unique DNA sequences are associated with diseases, pathogens, and many agents associated with bioterrorism. Detection of DNA from these agents can be employed as a method to detect their presence or absence. Our research involves the synthesis of a class of non-natural molecules (called PNAs) that bind to specific DNA sequences. We can design our molecules to bind to any sequence of DNA, and this past year we have found that our molecules are extremely good at selective recognition of DNA associated with anthrax. Currently, we are combining our molecules with detection devices to create a robust and reliable system for detection of anthrax and other pathogens.